Personalized Anesthesia: The Role of the Locus Coeruleus in Individual Anesthetic Responses

PROJECT SUMMARY/ABSTRACT
Millions of patients are placed into a reversible state of unconsciousness by anesthesiologists for life saving
surgeries every year. The basic goals of anesthetic care are to reliably extinguish consciousness for the
duration of surgery and afterwards to swiftly return the patient to their baseline cognitive state. Neither of these
goals can be reliably achieved today, however. Some patients regain consciousness during surgery. Episodes
of consciousness are not reliably detected by current intraoperative EEG-based monitoring and can result in
post-traumatic stress and anxiety disorders. In contrast, other patients take a long time to resume normal
cognition. This can manifest as postoperative delirium and cognitive derangements. Postoperative delirium
affects millions of patients, costs 34 billion dollars annually, and can be a harbinger of ongoing cognitive
decline. Such persistent impairments in cognitive function can last for many months. It is presently unclear
why some patients experience peri-anesthetic complications while other patients that receive
seemingly identical anesthetics have an uneventful perioperative course. To address this, we propose to
study individual-based anesthetic pharmacology rather than the previous population-based approach.
We have recently developed experimental and computational methods to quantify individual-based
measures of anesthetic responses in mice. Using these methods, we discovered that conventional
population-based pharmacological concepts such as drug potency are not sufficient to describe individual
responses. We identified two independent measures that do capture the range of individual responses:
sensitivity and resistance to state transitions (Rst). Sensitivity describes how often an individual is awake or
anesthetized at an anesthetic dose, while Rst describes how frequently transitions happen between awake and
anesthetized states. We demonstrated that pharmacology can differentially modulate sensitivity and Rst. We
also demonstrated that chemogenetic activation of an arousal pathway – the locus coeruleus – decreases Rst
without a change in drug sensitivity. Because Rst is completely obscured in population-based pharmacological
studies, we hypothesize that Rst is the hidden variable that may help explain why some patients
experience peri-anesthetic complications while others do not.
We propose to investigate the mechanisms through which the locus coeruleus decreases Rst. Using
pharmacologic and genetic approaches, we will identify the neurotransmitter systems used by the locus
coeruleus to modulate Rst. Separately, we will identify the effects of the locus coeruleus on neurophysiologic
state change, including correlates of behavioral Rst, using a high-density EEG system developed by our lab.
Finally, we will identify the neuronal pathways through which locus coeruleus acts to modulate Rst. The
proposed lines of investigation will clarify how activity of the locus coeruleus influences individualized
anesthetic responses, and will be an important step towards delivering personalized anesthesia.

Public health relevance
PROJECT NARRATIVE For the tens of millions of patients who receive general anesthesia every year, it is still unclear why some patients experience peri-anesthetic complications while other patients that receive seemingly identical anesthetics have an uneventful perioperative course. In order to be able to tailor an anesthetic to the needs of an individual patient, we plan to investigate individualized measures of response to anesthetics, and the neural pathways that can affect those individual differences. We propose to investigate how the major adrenergic center of the brain, the locus coeruleus, changes one of those individualized measures, how stable a patient is in the awake or anesthetized state.